Improving Diagnostics and Neurocognitive Outcomes in HIV/AIDS-related Meningitis

Central nervous system (CNS) infections are common across all ages in Sub-Saharan Africa in people with
or without HIV-infection. In persons with HIV, cryptococcal meningitis has historically been the second most
common AIDS-defining illness in Africa and the most common cause of adult meningitis in Sub-Saharan Africa
overall. The next most common cause of meningitis is likely TB meningitis, although CSF diagnostics are
challenging. With the widespread availability of antiretroviral therapy (ART), long term survival in persons living
with AIDS and CNS infections should be possible, but delayed or inaccurate diagnoses and limited therapeutic
options contribute to poor outcomes. Furthermore, with the ‘test and treat’ strategy of immediate ART initiation,
more people are presenting with CNS infections unmasked after starting ART, yet their outcomes are unclear.
We propose to continue a prospective cohort study of 1200 new HIV-infected persons presenting with
suspected CNS infection in Kampala and Mbarara, Uganda. We will use point-of-care and molecular
diagnostics to rapidly determine the etiologies of CNS infections, with a specific focus on optimizing and
validating new diagnostic tests, such as a semi-quantitative cryptococcal antigen (CrAg-SQ) lateral flow assay
and the Xpert MTB/RIF Ultra for TB meningitis. Second, we propose to conduct phase II trial investigating the
microbiologic effects of a novel oral antifungal agent (APX001) that inhibits fungal GWT1 enzyme blocking
fungal mannoprotein transport to the cell wall surface and is synergistic with fluconazole. Finally, we will
measure neurocognitive performance to investigate the effect of recent ART initiation on neurologic outcomes.
Specific Aims
1. Determine the etiology of CNS infections in Sub-Saharan Africa among HIV-infected adults through use of
a stepwise diagnostic algorithm coupled with next-generation sequencing and post-mortem exams.
2. Determine in HIV-related cryptococcal meningitis if oral APX001, a novel fungal GWT1 (GPI-anchored wall
transport protein 1) inhibitor, achieves with concomitant fluconazole a non-inferior rate of CSF
Cryptococcus clearance as compared with IV amphotericin B deoxycholate and fluconazole.
3. Determine if neurocognitive outcomes in HIV-infected persons presenting with CNS infections unmasked
after recent ART initiation are worse than in ART-naïve persons presenting with CNS infections.
Hypotheses:
1. We hypothesize in the ART era that cryptococcal and TB meningitis remain the two most common
etiologies of meningitis in an HIV-infected population despite the ‘test and treat’ ART strategy.
2. We hypothesize that APX001, a novel broad spectrum oral antifungal agent is well tolerated and will have a
non-inferior rate of CSF sterilization compared with IV amphotericin B in cryptococcal meningitis.
3. We hypothesize neurocognitive outcomes are worse in CNS infections unmasked on ART vs. ART-naïve.

Public health relevance
8. Project Narrative Meningitis is the second most common AIDS defining illness in Sub-Saharan Africa causing approx. 15-20% of the AIDS-attributable mortality in Africa. Overall Cryptococcus and TB are the two most common causes of meningitis in Sub-Saharan Africa; however, a significant number of brain infections are of unknown etiology. This project seeks to test new diagnostics and new innovative oral therapies for fungal meningitis in order to improve survival and neurologic outcomes.